A Solid-Phase, Long-Acting CCR5 Monoclonal Antibody for HIV Transmission

PROJECT SUMMARY
With 36 million people currently living with HIV worldwide and no vaccine currently available, developing a pre-
exposure prophylactic (PREP) HIV regimen that protects against sexual transmission remains a top global health
priority. Recently, a CCR5 blocking monoclonal antibody, Leronlimab, has shown exceptional safety, tolerability,
and anti-HIV activity in multiple clinical trials. Given that sexual transmission of HIV is almost exclusively
mediated by CCR5-tropic variants, Leronlimab may be extremely effective as a PREP reagent. We confirmed
the ability of once-weekly administered Leronlimab to protect macaques from rectal transmission of CCR5-tropic
SHIV. However, a once-quarterly at home formulation would dramatically increase patient adherence. To this
end we will develop a novel formulation of long-acting Leronlimab that can be administered at home in a low
volume able to provide coverage for three months. In specific aim 1, we will determine the pK and receptor
occupancy of this new Leronlimab formulation in blood and tissue sites of sexual transmission. In specific aim 2,
we will determine the length of time a single injection at the clinical dose can protect both male and female
macaques against rectal transmission. In specific aim 3, we will determine the length of time a single injection of
the clinical dose can protect against vaginal transmission in cycling female macaques. These studies will
determine the optimal clinical dosing of long-acting Leronlimab and lay the foundation for testing long-acting
Leronlimab clinically as PREP in individuals at high-risk of acquiring HIV via sexual transmission.

Public health relevance
PROJECT NARRATIVE The development of a pre-exposure prophylactic reagent that potently inhibits transmitted HIV with minimal toxicity, lack of potential for drug-drug interactions, and infrequent dosing would greatly slow the HIV epidemic. Given that nearly all mucosally-transmitted HIV is CCR5 tropic, we will test the ability of a novel, extended half- life CCR5 blocking antibody formulated for maximum concentration to prevent mucosal transmission of HIV using the macaque model. Success of these studies would establish a new, user-friendly pre-exposure prophylactic weapon for the fight against HIV.